High Frequency Wearable and Transparent Electrostrictive Row-Column Arrays for Whole Brain Functional Imaging

Project Summary/Abstract Section

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.

We propose the development of a novel bias-switchable row-column 2D ultrasound transducer array technology for 3D ultrasound and photoacoustic imaging of whole-brain functional activity with potential for a wearable format for awake and moving animals. These can be developed into high- frequency arrays and even transparent variants that should allow optical and ultrasonic imaging down to resolutions of 30 microns, approaching single-neuron scales. Unlike previous 2D array technologies that require wires connecting to each transducer element, our approach requires only row- and column addressing, yet permits readout from every element of the array using novel electrostrictive bias switching approaches. The technology promises first-of-it’s kind volumetric functional brain imaging of blood-flow changes, blood oxygenation changes, and even neuron activity over the whole brains of awake and moving rodents. The array offers significant potential for next-generation neuroscience experiments involving both optical and acoustic methods, including future work combining functional ultrasound and photoacoustic imaging with optogenetics, optical microscopy of genetically-encoded reporters of neuron activity, ultrasound neuro-stimulation, ultrasound blood-brain barrier disruption for drug delivery, and more. The arrays have considerable translational potential for future human subject imaging in neurosurgeries, neonates, and with potential for implantable devices for longitudinal functional brain imaging. Our research methods include careful design and fabrication of these high-frequency arrays with special attention to transparent variants. We also develop novel imaging schemes and implement these schemes on programmable ultrasound systems. Testing will include array characterization, imaging phantoms, imaging cells expressing near-infrared (NIR) genetically-encoded reporters of neuron Calcium activity. If successful, future work will go on to implement animal imaging experiments aiming to visualize functional brain imaging due to whisker stimulation in both anesthetized and awake- moving animals.

Public health relevance
Public Health Relevance Section Enter the text here that is the new public health relevance information for your application. Using no more than two or three sentences, describe the relevance of this research to public health. New high-resolution 3D ultrafast ultrasound and optical brain imaging technology will be developed that is capable of better understanding whole brain function at close to neuron-scales. This approach will be many times faster than existing functional MRI systems and provide thousands of times finer volumetric resolution for studying the brain in ways that were previously not possible.